Sustainment of Mental Health Supports in Under-Resourced Urban Schools

PROJECT SUMMARY / ABSTRACT
The school is a key setting for the delivery of mental health services to children. School-wide positive behavior
interventions and supports (PBIS), a service delivery strategy based on the public health model, is a useful
vehicle for implementing mental health EBPs. In PBIS, schools implement universal (Tier 1) interventions to
improve school climate and safety, and can employ targeted (Tier 2) group interventions for children with or at
risk for mental health disorders. Very little research has been conducted on using mental health EBPs at Tier
2. Adequate and ongoing training opportunities are frequently identified as “essential practices” needed to
successfully sustain the benefits of interventions. School personnel, with or without prior mental health training,
can implement Tier 2 interventions with fidelity and clinical effectiveness when provided adequate support.
School mental health programs that successfully implement targeted group interventions often use ongoing
supervision from internal supervisors. A number of studies have shown that more experienced school
personnel can successfully be trained to serve as coaches and supervisors for those implementing EBPs. In
order for these schools to receive the potential public mental health benefits of targeted mental health
interventions in schools, an efficient, scalable, cost-effective and sustainable model of training and consultation
that can be transferred from experts to school coaches and from coaches to EBP implementers is needed.
Little is known about which models of support for sustainment are effective, feasible, and cost-effective.
The aims of the study are (a) to compare fidelity, cost-effectiveness, and student outcomes of Tier 2 mental
health interventions across 2 sustainment conditions, (b) assess mediators and moderators of consultation
support on implementation fidelity, and (c) assess perceived feasibility and acceptability of consultation
support.
The study proposes to use a 2-arm, randomized controlled trial, Type 2 Hybrid cluster randomized design.
Sixty school personnel from 12 schools will receive full initial implementation support for 1 year and then will be
randomly assigned to receive one of 2 sustainment conditions: (a) remote consultation provided by school
district coaches who themselves will be receiving remote support from expert external consultants
(Sustainment 1 [S1]); and (b) consultation as usual provided by district coaches with no external support
(Sustainment 2 [S2]). S1 will have a period of diminished support followed by a period of no support. The
interventions to be implemented by school personnel are EBPs for the most common externalizing and
internalizing mental health disorders. Our guiding framework is the Interactive Systems Framework (ISF) for
dissemination and implementation research. The results of the proposed study will provide a scalable and cost-
effective strategy for the sustainment of PBIS mental health supports in under-resourced schools.

Public health relevance
PROJECT NARRATIVE This study is likely to result in a feasible, effective, and cost-effective strategy for the sustainment of PBIS with mental health supports in under-resourced urban schools. Linking PBIS with state-of-the-art mental health supports and well-trained school personnel will likely lead to improvement and sustainment of student mental health and academic engagement.